Decision-Making and Episodic Memory in Trajectories to Cannabis Addiction

DESCRIPTION (provided by applicant): More people in the United States are addicted to cannabis than to any other illicit drug, and prevalence of its use is rising, accompanied by a decline in the disapproval of its use and its perceived harm among adolescents. Important maturational changes in prefrontal cortex during adolescence may make youth more vulnerable than adults to adverse effects from cannabis. Indeed, research shows impairments in memory performance and decision-making abilities of heavy cannabis users, most of whom initiate use during adolescence. However, little is known about how decision-making and memory are affected across the trajectory from initial experimentation to development of cannabis addiction. Furthermore, there is controversy in the scientific literature on whether the impairments in decision-making observed among heavy cannabis users are due to the harmful effects of cannabis on brain functioning, or whether they may be an antecedent risk factor for the development of cannabis addiction. The principal goals of this proposal are to determine whether: a) decision-making is an antecedent risk factor for cannabis addiction; and b) what changes occur in decision-making and episodic memory along different cannabis use trajectories. Participants will be 400 youth ages 14 to 16 at baseline, most of whom will have experimented with cannabis, but have yet to develop addiction. Over two years, their performance will be assessed on measures of decision-making and episodic memory every 12 months and on their substance use and symptoms of cannabis addiction every 6 months. Poorer decision-making at baseline is hypothesized to be associated with increased risk of developing cannabis addiction during follow-up. Those who escalate in their cannabis consumption over time will show greater deterioration in their episodic memory than observed in other (non-escalating or desisting) cannabis use trajectories. In contrast, decision-making will show little change across all trajectories, consistent with its hypothesized role as an antecedent, rather than a consequence, of cannabis addiction. Any declines observed in decision-making during follow-up are hypothesized to be associated with increased severity of cannabis addiction (i.e., more compulsive use and more negative consequences), but less so with cumulative lifetime amounts of cannabis use. The opposite pattern is expected with memory performances. Understanding more about the links between neuropsychological functions and cannabis addiction will help clarify theoretical models pertaining to their temporal association. Clinically, knowing more about neuropsychological predictors and sequelae of addiction will help us to develop more targeted and tailored interventions and prevention programs, consistent with NIDA's goals. Importantly, our findings will clarify whether decision-making is an antecedent risk factor for cannabis use and addiction, a consequence of use, or both. PUBLIC HEALTH RELEVANCE: People who use marijuana sometimes show impairments in their memory and in the way that their brain makes good decisions. This study will help to determine if problems with decision-making are one of the reasons that some teens become addicted to marijuana. It will also describe how progressing from experimental marijuana use to addiction affects memory and decision-making. Knowing more about predictors of marijuana addiction will help us to develop specific interventions and prevention programs for teens.

Public health relevance
People who use marijuana sometimes show impairments in their memory and in the way that their brain makes good decisions. This study will help to determine if problems with decision-making are one of the reasons that some teens become addicted to marijuana. It will also describe how progressing from experimental marijuana use to addiction affects memory and decision-making. Knowing more about predictors of marijuana addiction will help us to develop specific interventions and prevention programs for teens.